St. Vincent Hospital Regional Cancer Center CCOP

[unreadable] DESCRIPTION (provided by applicant): [unreadable] The St. Vincent Hospital Regional Cancer Center (SVRCC) CCOP is dedicated to the prevention and treatment of cancer in the population it serves. The SVRCC CCOP is composed of St. Vincent Hospital, St. Mary's Medical Center, Bay Area Medical Center, Green Bay Oncology, Radiation Oncology Specialists and Prevea Clinic. The SVRCC CCOP is located in Green Bay, Wisconsin and serves the people of 13 counties in Northeastern Wisconsin and the Upper Peninsula of Michigan. The broad long-term objectives of the SVRCC CCOP are the prevention of cancer and the effective treatment of cancer. The SVRCC CCOP is committed to cancer research as a means to achieve those objectives. The specific aims of the SVRCC CCOP are fourfold: 1) To provide our care givers with the newest ideas for cancer treatment; 2) To provide the newest drugs and techniques for our patients; 3) To promote cancer prevention; 4) To broaden the number of clinical specialties participating in clinical research. The research design and method is to provide and promote National Cancer Institute sponsored Cooperative Group Trials. [unreadable] [unreadable]